Understanding Treg-mediated modulation of microglia in breast cancer brain metastasis

PROJECT SUMMARY
Metastatic brain tumors represent the most common form of malignancy in the central nervous
system. In women with metastatic breast cancer, up to 35% of patients will suffer from brain
metastasis and will have little to no therapeutic options to treat them. Current treatments are often
complicated by the protected environment of the brain with its blood-brain barrier, distinct
anatomical structure, metabolism, and unique immune composition. Given the high prevalence of
breast cancer in women in the United States, this poses a significant unmet clinical need. Immune
modulation represents a promising therapeutic approach, but the efficacy of these treatments is
often hindered by the presence of suppressive immune cells, such as regulatory T cells (Tregs).
Tregs are a population of immunosuppressive cells that serve to control immune responses and
prevent autoimmunity. Tregs have been reported to be present in brain metastases and have
been used as a prognostic factor in tumor progression and patient outcomes. Systemic depletion
of Tregs can promote anti-tumor immunity, but this approach also confers unwanted systemic
autoimmunity. Thus, specific mechanisms to target Treg function in the brain without completely
depleting them is necessary. My preliminary data demonstrates that Tregs accumulate readily
within brain metastases and their depletion confers a complete elimination of tumor mass. This
response results from an enhanced effector T cell infiltration and an enriched antigen presentation
program in microglia, the brain-resident macrophage population. Co-depletion of microglia in Treg
depleted mice results in a complete reversal of this tumor rejection. This emphasizes the central
role that microglia play in the anti-tumor response in brain metastases and demonstrates a need
to target Treg-microglia interactions in this setting. To this end, the proposed study will aim to
understand and target Treg modulation of microglia, allowing for the potent and brain-specific
targeting of Treg function. First, I will determine if antigen presentation is a central microglial
function suppressed by Tregs to identify targets to inhibit Treg function specifically within the brain.
I will also assess the therapeutic potential of deleting CD73, an ecto-5’-nucleotidase expressed
on Tregs that converts AMP into adenosine, which has been shown to suppress microglia function
through A3R, an adenosine receptor exclusive to microglia. This work will pave the path to the
generation of novel therapeutics to impair Treg-mediated suppression in the brain and generate
desperately needed treatments for patients with brain metastases.

Public health relevance
PROJECT NARRATIVE Brain metastasis is a fatal disease with limited therapeutic options that impacts the lives of hundreds of thousands of Americans diagnosed with metastatic cancer. Regulatory T cells (Tregs) are immune cells that play a significant role in the progression of this disease, yet the exact mechanisms by which they contribute are unknown with no means to target them. This proposal will use single-cell RNA sequencing and functional studies to understand how Tregs suppress microglia, a key brain-resident player in the tumor response, and will evaluate the efficacy of targeting a potential interaction between these two cells as a novel therapeutic for brain metastasis to improve patient outcomes.